Core B: Biospecimen Repository and Processing Core

CORE B ABSTRACT
Recent advances in the treatment of metastatic melanoma with targeted therapies are highly successful initially
but are ultimately limited by the development of tumor resistance. On the other hand, checkpoint inhibitors are
associated with durable responses but only benefit a minority of patients. The aims of all of the projects in this
application are to understand the mechanisms and develop strategies to overcome resistance to both combined
targeted therapies and checkpoint inhibitor immunotherapies in melanoma. The proposed studies require an
efficient Biospecimen Core that can provide a variety of high quality biospecimens to the investigators. The
specific aims of the Biospecimen Repository and Processing Core (BRPC - Core B) of the PPG are to: 1 )
Centralize performance of specialized pathology services, including biosample (tissue and biofluid) storage,
tracking, distribution and analysis; 2) Provide well-characterized melanoma tissues, cell lines and short-term
cultures from patients enrolled on combination therapies and treated with BRAF/MEK inhibitors or checkpoint
inhibitors and prospectively develop additional cell lines; and 3) Develop techniques to better characterize cells
from within the tumor microenvironment for more sophisticated analysis in situ and at the single cell level. BRPC
provide the advanced expertise in melanoma biology, cell line development, pathologic interpretation and
biorepository management that is required by all proposed studies.

Public health relevance
CORE B PROJECT NARRATIVE The proposed projects of this PPG seek to understand the molecular and cellular basis for mechanisms and resistance to targeted therapy or checkpoint inhibitors to allow the rational design of combinatorial therapies that treat and eventually prevent resistance. These studies rely heavily on patient-derived samples collected both at UCLA and provided by outside collaborators through the Biospecimen Repository and Processing Core (BRPC). Core B will serve for obtention, generation, and authentication of biomaterial (tissue and biofluid) from patient samples; as well as provide advanced expertise in melanoma biology, cell line development, pathologic interpretation and biorepository management for all proposed studies.